Stimulation-induced modulation of fronto-limbic responses to threat

PROJECT SUMMARY/ABSTRACT
There are bidirectional neurobiological links between anxiety and epilepsy. However, the specific processes
linking these conditions remain unclear. Stereo-electroencephalography (sEEG) is a critical tool for localizing
the ictal onset zone in patients with treatment-resistant epilepsy (TRE) undergoing evaluation for resective
surgery and provide an ideal approach to study the disruptions in the distributed networks that underlie this
link. Further, investigation of these circuits and their causal impact on human behavior and cognition is
possible through the delivery of electrical stimuli via the already implanted sEEG electrodes. The proposed
work will assess anxiety-related disruptions in emotion regulation neurocircuitry using sEEG and test how
stimulation to dorsomedial prefrontal cortex modulates the underlying networks in TRE. Completion of the
proposed work will provide a causal understanding of the link between fronto-limbic network functions, anxiety,
and epilepsy. The knowledge gained from this study will be applied to the field of mental health research to
identify critical network nodes related to anxiety and demonstrate that this circuit can be modulated by
electrical stimulation. The central hypothesis is that TRE is associated with disruption in the function of the
fronto-limbic network (i.e., prefrontal cortex; amygdala), and in turn, this dysfunction disrupts healthy emotion
regulation resulting in anxiety symptoms (Aim 1). Further, stimulation of dorsomedial prefrontal regions will
directly influence anticipatory regulation of amygdala responses to threat (Aim 2).
These aims will be accomplished in the context of a formal research plan, supported by a team of researchers
with relevant expertise. Additionally, the data generated during the R21 effort will gather the preliminary data
required for a competitive R01 randomized clinical trial application. The University of Alabama at Birmingham
offers state-of-the-art research expertise and resources that will also serve to prepare this proposal for
success. Specifically, the proposed work will utilize advanced sEEG recording and stimulation techniques,
including functional connectivity and behavioral measures of emotion processes, one of the nation’s top
epilepsy research and treatment centers, and a dynamic network of clinical research expertise, cores, and
laboratories.

Public health relevance
PROJECT NARRATIVE/RELEVACE TO PUBLIC HEALTH This project investigates neuromodulation of emotional responses using intercranial depth electrodes and the relationship between anxiety symptoms and these responses in treatment resistant epilepsies (TRE). This research is expected to identify brain areas that mediate emotion network dysfunction, leading to anxious symptom experience. The research project will identify potential treatment targets for anxiety and epilepsy disorders and provide data for a subsequent R01 clinical trial proposal.